Facilitating Health System Implementation of Physical Activity Screening and Referral to Community-Based Programs: Exercise is Medicine Greenville

Project Summary
There is great potential for promoting physical activity (PA) for chronic disease prevention and treatment
through the health care sector. Research has demonstrated effectiveness in assessing patient PA levels,
providing ‘exercise prescriptions’, and referring patients to evidence-based PA programs in community
settings. However, implementation barriers exist, ranging from practice integration to information flow, resulting
in no major health systems integrating PA as part of a comprehensive approach to patient care. In 2016, a
multi-organizational partnership between a large academic healthcare system, an academic institution, and a
national PA organization launched Exercise is Medicine Greenville (EIMG), a comprehensive clinic-to-
community approach that involves PA assessment, prescription, and referral of patients with chronic diseases
to a tailored, community-based PA program. Since 2016, EIMG has expanded to 35 Prisma Health primary
care clinics and 7 community PA facilities covering >400 miles2. Despite referring >1900 patients to date, great
variability exists across participating clinics in correctly identifying eligible patients and providing EIMG
referrals, reducing the overall reach and efficiency of engaging patients in the community-based PA programs.
Using a pragmatic, stepped wedge, cluster randomized design, we will examine the impact of implementation
facilitation (IF) on improving the implementation and reach of EIMG with patients visiting participating Prisma
Health primary care clinics. At six-month intervals, 24 randomly selected clinics (6 clinics per wave; 4 waves)
will receive IF planning (3mos), active IF (6mos), and post-IF maintenance (min 12mos). The specific aims of
this project are to: 1) determine differences in the level of implementation (i.e., delivery fidelity) and reach (i.e.,
number, proportion, representativeness of patients) at Prisma primary care health clinics before and after IF, 2)
assess levels of patient engagement in and the effectiveness of the 12-week, community-based PA programs,
and 3) evaluate the costs of IF and the effects of increased EIMG referrals to the community-based PA
program on patients costs and clinical outcomes. Our mixed methods evaluation approach is guided by the
RE-AIM framework to inform the assessment of implementation outcomes, and the i-PARIHS framework to
describe contextual factors (i.e., determinants) influencing patient and clinic level outcomes. Through this work,
we will identify successful IF strategies across heterogeneous health settings, helping us identify and address
potential inequities in the types of patients that receive EIMG referrals, are engaged in the EIMG referral
pathway, and enroll and complete the community-based PA program. Study findings will provide important
information on improving future implementation and scalability of PA integration in large health systems,
optimizing clinic-community linkages, and the cost savings related to primary and secondary prevention of
cardiovascular disease-related health outcomes in the general patient population.

Public health relevance
Project Narrative A public health priority exists for the U.S. healthcare sector to integrate physical activity (PA) as a part of the patient care model. This research will provide valuable information on facilitating optimal implementation of a clinic-to-community model in a large U.S. healthcare system that identifies, refers, and enrolls physically inactive patients to community-based PA programs for the prevention and treatment of chronic diseases. Further, this work will provide evidence on the cost-effectiveness of integrating PA in healthcare systems as a population health management strategy.